Individualized Prediction of Progression to Heart Failure Using Digital Twins, an Explainable Reinforcement Learning Approach

PROJECT SUMMARY
Heart failure (HF) will affect one in four Americans during their lifetime. It is associated with a 50% 5-year
mortality, disproportionately burdening individuals who experience accelerated decline in cardiac function. In
most patients, cardiac dysfunction starts with an adaptive asymptomatic stage, before eventually progressing to
symptomatic HF. Although current methods are excellent to identify population level HF risk, they are limited in
identifying if or when any given individual develops HF symptoms. Extra-cardiac comorbidities are likely
important contributors to heterogeneity observed in HF susceptibility and clinical presentation. Critically,
traditional non-invasive measures of cardiac function perform poorly in discriminating HF patients from their
comorbidity-matched symptom-free counterparts. The lack of effective approaches to identify individuals at risk
of HF is a critical barrier to identifying and preventing HF. There is, thus, an urgent need to develop personalized
methods to understand the natural history and progression to overt HF on an individual level. Our goal is to study
the effect of an individual’s comorbidity profile on their cardiac structure and function in early HF using explainable
machine learning. Our central premise is that individual comorbidity profiles differentially modify pathophysiologic
mechanisms of HF, which can be detected using a virtual digital heart, a “digital twin”. Leveraging rich data from
4,483 participants from the longitudinal NHLBI-funded Atherosclerosis Risk in Communities (ARIC) study free
of HF, we will characterize cardiac performance at an individual level using primary echocardiographic images,
quantitative echocardiographic measures, and arterial pulse wave velocity. We will then use domain-guided
mechanistic reinforcement learning to simulate cardiac adaptation, conditioning on known HF-related
comorbidities including body composition, obesity, renal function, pulmonary function, skeletal muscle strength,
and frailty. Additionally, we will use circulating serum protein biomarkers to evaluate biological mechanisms of
HF. We will leverage the longitudinal NHLBI-funded Atherosclerosis Risk in Communities (ARIC) study. Our
specific aims are to (1) define individualized comorbidity-driven risk of HF in asymptomatic older adults; and (2)
to identify echocardiographic patterns in asymptomatic older adults that predict future HF onset. These studies
will yield a novel personalized model of HF progression, providing critical insights into cardiac dysfunction at an
asymptomatic stage and its trajectory. This study will be performed by Pranav Dorbala, an MD/PhD student at
the University of Illinois Urbana Champaign pursuing a PhD in machine learning. His sponsor has extensive
expertise in machine learning for health care applications and his co-sponsor is an established ARIC investigator
with extensive experience in cardiovascular epidemiology, quantitative echocardiography, and high dimensional
data. Completion of the proposed studies will serve to train the student in the fundamentals of becoming a
physician-scientist in the field of personalized medicine.

Public health relevance
Project Narrative Heart failure (HF) is an urgent public health problem where specific individuals of the population demonstrate markedly elevated risk of developing HF. This project will develop a personalized precision medicine approach to identify HF before symptoms begin and predict individualized HF risk using a digital twin, an advanced explainable machine learning method, leveraging information on blood biomarkers, organ function measures, and ultrasound images of the heart. The results of this novel study are vital to inform the future interventions to prevent HF, and thereby decrease HF-associated morbidity and mortality.